stress reduction intervention in caregivers

Subjects are accrued to this protocol once they have been identified and are serving as a primary caregiver for an individual planning to undergo an allogeneic HSCT at the Clinical Center, NIH. The patient and caregiver(s) are approached for participation before the patient starts their transplant conditioning. A sample of at least 78 caregivers is needed to adequately evaluate the effectiveness of the intervention for the planned primary analysis. Recruitment began in January 2015, and remains ongoing at this time. A total of 202 HSCT patients have been screened, 49 enrolled, 11 withdrew consent, and 38 have completed enrollment and study procedures. The study continues to enroll to meet protocol objectives.